Telluride Workshop on Challenges in RNA Structural Modeling and Design

DESCRIPTION (provided by applicant): The heightened appreciation for the central role of RNA molecules in all cellular processes - from catalysis to control of gene expression to cellular differentiation - combined with the practical applications of synthetic RNAs in biomedicine and biomolecular engineering have raised new challenges regarding RNA structure analysis, prediction, and design to both experimental and theoretical scientists. These challenges have produced many innovative approaches, including interdisciplinary efforts, to analyze, predict, simulate, and design RNA molecules. While many successes have been reported, progress in the field has been hampered by limited experimental resolution and an incomplete understanding of RNA tertiary structure, especially for large RNAs. Though RNA structure is believed to be hierarchical, the difficult problem of understanding and predicting its tertiary structure from its primary as well as secondary structure remains unsolved in general. In addition, some database issues and limited coordination of RNA archives have emerged. To advance this important scientific frontier, we will hold TSRC meetings in Summers 2014 and 2016 to bring leading experimentalists and modelers to discuss and advance the field. We aim to create a core working group to bring together scientists working on both the genomic and molecular levels of RNA using novel experimental, mathematical, statistical, and computational methods. By familiarizing scientists from disparate disciplines with the challenges, and presenting current efforts, advances, and ideas, we hope to catalyze new approaches and collaborations in this important field, identify gaps in knowledge and areas for progress, and address these gaps after the first meeting via focused problems by the second meeting in 2016. Support by the NIH will help not only improve the workshop, but also provide NIH direct feedback on the participants' dialog and outcomes via resulting meeting reports and direct communications.

Public health relevance
PUBLIC HEALTH RELEVANCE: RNA molecules are essential cellular components that play a central role in all biological processes. With many practical applications of synthetic RNAs in biomedicine and biomolecular engineering, this conference aims to bring together scientists working on both the genomic and molecular levels of RNA. By familiarizing scientists from disparate disciplines with the challenges and presenting current efforts, advances, and ideas, we hope to catalyze new approaches and collaborations in this important field and form a core working group to address gaps of knowledge.